Protocal Review & Monitoring System

I. Purpose The Mayo Clinic Cancer Center (MCCC) oversees protocol development and review through its Protocol Review and Monitoring System (PRMS). The PRMS contains several elements including the Disease/Discipline Oriented Groups (DOGs), the Hematology Research Committee (HRC) and the Oncology Review Committee (ORC). A portion of PRMS activities, as described below, is also accomplished through the Cancer Center Clinical Research Administrative Subcommittee (CCCRAS) and the Cancer Center Clinical Studies Oversight Committee (CCCSOC).